Big data apprOaches fOr Safe Therapeutics in Healthy Pregnancies (BOOST-HP)

PROJECT SUMMARY/ABSTRACT
In the US, pregnant patients use 4 medications on average, and 70% use at least one. Yet, most drugs lack
conclusive evidence about safety during pregnancy: of 290 new FDA labels approved between 2010 to 2019,
90% contain no human data on the risks or benefits for pregnant patients. With current evidence generation
systems, the mean time for evidence development in pregnancy has been estimated at 27 years, which is too
long. Current evidence generation relies largely on observational studies, typically prompted by signals from
animal studies or extrapolation from known pharmacological pathways, which may miss pregnancy-specific
context. Insufficient attention is also given to identifying causal mechanisms in vulnerable sub-populations at
greatest risk. Building on our prior work in data-mining in FDA’s Sentinel System and CDC’s Vaccine Safety
Datalink, conduct of pharmacoepidemiologic studies to evaluate prenatal medication safety, and pilot work with
special focus on drug scans in pregnancy, we will implement a three-stage novel reverse translational
framework to accelerate evidence generation that will use data-mining (“scans”) to identify new exposure-
outcome associations, triage signals, and then formally evaluate top prioritized signals. To accomplish our
goals, we will use our infrastructure developed for drug evaluations in pregnancy, including curated billing
records from the NIH Collaboratory’s Distributed Research Network and the national Medicaid Information
System, representing a broad cross-section of privately and publicly insured pregnant patients and their
offspring. Our specific aims are: (Aim 1) To scan for associations between (1a) pregnancy loss and
antecedent prenatal exposures on the individual drug, chemical and therapeutic class level; and (1b) the 50
most prevalent drugs in pregnancy with incomplete information on teratogenic risk and a broad selection of live
birth adverse outcomes; and (1c) to prioritize signals via expert panel review. (Aim 2) To employ careful
pharmacoepidemiologic designs to evaluate the two top prioritized signals involving (2a) pregnancy loss, and
(2b) an adverse livebirth outcome. To control for confounding and measurement biases, these studies will
employ previously validated measures, which are further enhanced via linkage to fetal death and birth
certificate data for a cohort subsample to evaluate unmeasured confounding and conduct probabilistic
sensitivity analyses on outcome and exposure misclassification. Big data apprOaches fOr Safe Therapeutics in
Healthy Pregnancies (BOOST-HP) will offer an innovative advancement in evidence generation by evaluating
numerous exposures and outcomes simultaneously. Our long-term goal is to build a reusable, scalable
approach and infrastructure to accelerate evidence generation on the safety and effectiveness of medication
use during pregnancy. By leveraging data-mining methodologies successfully deployed in public health
surveillance along with infrastructure used by multiple federal government agencies, we will focus research
efforts on novel, high-priority signals that pose the greatest risk to healthy pregnancies.

Public health relevance
PROJECT NARRATIVE Drug exposure in pregnancy is common although data available to pregnant patients and their providers on the risks and benefits of drug use in pregnancy are sparse. Reducing adverse pregnancy and infant outcomes requires new approaches to address the insufficient pace of new information on safe use of medicines in pregnancy. In this study we will combine a) innovative data-mining techniques that can evaluate multiple drugs and outcomes simultaneously with b) formal assessments of prioritized safety signals obtained from data mining in real world populations.